Tobacco Control Policies and Individual-Level Trajectories of Youth Cigarette Use

DESCRIPTION (provided by applicant): While macro-level and repeated cross-sectional studies of tobacco control policies and smoking rates, as well as evaluative studies of new policies in specific geographic areas, provide some evidence of policy effectiveness, little research has examined how policies at various levels implementation (e.g. local, county, and state) affect within-individual trajectories (initiation, prevalence, duration, and cessation) of smoking during the critical teenage and young adult years. Without an approach that examines the full range of policies simultaneously nationwide on the same individuals over time, policymakers cannot adequately assess the efficacy of particular tobacco control policies and, thus, risk investment in non-effective regulations. Using nationally representative longitudinal data, a complete record of tobacco control ordinances, and innovative statistical methods, the goal of this project is to provide policymakers and health researchers with the tools to make the most informed tobacco control policy decisions regarding youth smoking prevention and intervention, including which individuals or locales are least susceptible to changes in behavior resulting from policy implementation. To fully understand how tobacco control policy affects youth smoking patterns over time, we require a geocoded, repeated observations dataset of youth cigarette use and predictive risk factors, a comprehensive database of tobacco control regulations, and a statistical method capable of handling a complex hierarchical data structure. We address those needs by merging data from the annually collected National Longitudinal Survey of Youth 1997 (NLSY97) with the Americans for Nonsmokers' Rights (ANR) national repository of tobacco ordinances and regulations, and using recent developments in hierarchical cross-classification models. To identify the main effect of tobacco policies on trajectories of youth cigarette use, we will combine the two geocoded datasets and analyze them with recently developed hierarchical cross- classification models. After controlling for well-known risk factors and local structural conditions, the efficacy of particular tobacco policies will demonstrate which policies should be adopted on a wider basis, ultimately impacting health and mortality and reducing costs to health care and society. To assess whether the effect of policy varies by characteristics of the individual or context, we will analyze interaction effects between individua-level characteristics and policy measures and local-level characteristics and policy measures, which will reveal if a given policy is more effective for certain types of individuals or those residing in similar areas. The lack of effectiveness of policies on certain individuals will expose the need for those policies to incorporate a component that addresses particular groups or areas. This proposal's innovation lies in both its examination of within-youth changes in smoking behavior over time as it relates to both previously examined and unexamined tobacco restrictions at various levels of implementation and in the development and furthering of innovative statistical approaches necessary for datasets that contain repeated observations on multiple levels.

Public health relevance
PUBLIC HEALTH RELEVANCE: This study will examine the effect of various forms of tobacco control policy on youth trajectories of smoking over time and variations in the effect of policy by characteristics of the individual and their local context. Specifically, through innovative hierarchical cross-classified models using a repeated observations dataset and a complete collection of local tobacco control policies, we will examine the ways in which changes in policies influence youth initiation, duration, prevalence, and cessation of cigarette smoking. By influencing the proliferation of the most successful tobacco control policies, the findings from this study will influence mortality rates and costs to public health as fewer youth become adult smokers. __SpecificAimsTextDelimiter__ Tobacco Control Policies and Individual-Level Trajectories of Youth Cigarette Use Specific Aims Since the 1964 Surgeon General's report linked smoking and health outcomes, there has been a proliferation of anti-tobacco policy measures in the United States, such as clean air ordinances, restrictions on youth access, restrictions on media, and increased taxation. Studies of such policies, however, have not examined how specific policies affect the trajectories (initiation, duration, prevalence, and cessation) of youth smoking, and how such effects may vary by background and geographic location. While macro-level and repeated cross-sectional studies of policies and smoking rates, as well as evaluative studies of new policies in specific geographic areas, provide some evidence of policy effectiveness, little research has examined how policies at various levels implementation (e.g. local, county, and state) affect within-individual trajectories of smoking during the critical teenage and young adult years. Without an approach that examines the full range of policies simultaneously nationwide on the same individuals over time, policymakers cannot adequately assess the efficacy of particular tobacco control policies and, thus, risk investment in non-effective regulations. Using nationally representative longitudinal data, a complete record of tobacco control ordinances, and innovative statistical methods, the goal of this project is to provide policymakers and health researchers with the tools to make the most informed tobacco control policy decisions regarding youth smoking prevention and intervention, including which individuals or locales are least susceptible to changes in behavior resulting from policy implementation. To fully understand how tobacco control policy affects youth smoking patterns over time, we require a geocoded, repeated observations dataset of youth cigarette use and predictive risk factors, a comprehensive database of tobacco control regulations, and a statistical method capable of handling a complex hierarchical data structure. We address those needs by merging data from the annually collected National Longitudinal Survey of Youth 1997 (NLSY97) with the Americans for Nonsmokers' Rights (ANR) national repository of tobacco-related ordinances and regulations, and by using recent developments in hierarchical cross- classification models. By linking these two datasets at the metropolitan area, county, and state levels, we can embed youth within their changing tobacco policy context. The repeated observation and contextual aspect of the multilevel cross-classification analysis will produce empirically stronger conclusions to guide future policy adoption than either aggregate or evaluative studies. Building upon our expertise in tobacco policy research, life course studies, and statistical and mathematical modeling, we propose the following aims: Aim 1 is to identify the influence of specific tobacco policies on trajectories (initiation, prevalence, duration, and cessation) of youth cigarette use. We will combine two geocoded datasets and analyze them with recently developed hierarchical cross-classification models. After controlling for well-known risk factors and local structural conditions, the efficacy of particular tobacco policies will demonstrate which policies should be adopted on a wider basis, ultimately impacting health and mortality and reducing costs to health care and society. Aim 2 is to determine if tobacco policies are more effective for particular subgroups of youth or those who reside in areas with certain structural characteristics. We will analyze interaction effects between individual-level characteristics and policy measures and local-level characteristics and policy measures, which will reveal if a given policy is more effective for certain types of individuals or those residing in similar areas. The lack of effectiveness of policies on certain individuals will expose the need for those policies to incorporate a component that addresses particular groups or areas. In addition to providing the first nationally representative repeated observations study of the effect of tobacco control policies on within-individual variations in cigarette use through the transition to adulthood, this project will contribute to tobacco research in several additional ways. First, given the documented link between teenage smoking and heavy adult smoking, if the presence of particular policies reduces youth smoking, it would decrease the number of subsequent adult smokers and the resulting negative health effects, ultimately affecting mortality rates. The results will provide policymakers with strong evidence for the adoption and continuance of specific policies, particularly as they relate to the most formative years. Second, identifying effective policies could lead to decreases in healthcare expenditures, as well as secondhand smoke exposure. Third, the results will demonstrate which policies need to be reevaluated and redesigned if they do not directly affect tobacco use and if those policies need to be aimed at certain individuals or particular areas, with the latter important due to the disparity in smoking rates by certain risk factors.